Epigenetic dysregulation in APC-negative colorectal cancer

The incidence of colorectal cancer (CRC) is higher in African Americans (AAs) compared with US whites
(NHWs) overall, but the disparity is more extreme in persons with earlier age of onset. The median age of
onset is 65 in AAs compared to 72 in NHWs, and early-onset CRC is more than twice as frequent in AAs than
in NHWs. In addition, epidemiologic evidence suggests that younger age CRCs may have a more rapid
progression through the steps of carcinogenesis. Yet, younger age CRC is not well characterized in any
population, and we have no explanation for its higher incidence in AAs. In a recent genomic analysis of a
series of Chicago African American CRC cases, we found an excess of CRCs lacking mutation in the tumor
suppressor gene APC (APC mutation-negative CRCs). Microsatellite stable APC mutation-negative CRCs
were associated with younger age of diagnosis, fewer numbers of somatic mutations, and microsatellite and
chromosome stability. Importantly, we discovered that APC mutation-negative CRCs exhibited a novel
methylation profile characterized by increased levels of methylation in key cancer driver genes including those
in stem-cell maintenance and the WNT signaling pathway. Based on our preliminary data, we hypothesize that
epigenetic dysregulation in APC mutation-negative CRCs drives specific DNA methylation changes and gene
regulatory networks that maintain a stem-like cancer phenotype. The overall goal of the project is to
characterize the molecular mechanisms that drive this novel subtype of CRCs. We have three aims. Aim 1.
Identify and characterize significant differentially methylated regions in AA CRC. Hypothesis: Tumor-
specific differentially methylated regions are associated with carcinogenesis in APC mutation-negative CRCs.
APC mutation-negative CRCs will be associated with earlier age of onset and with distinct molecular and
clinicopathological features. Aim 2. Identify and characterize differentially expressed genes and
regulatory networks in AA CRCs. Hypothesis: Specific regulatory networks that maintain a stem-like cancer
phenotype are associated with APC mutation-negative CRCs. Aim 3. Determine driver gene dependencies
of AA CRCs in organoid cancer models. Hypothesis: Suppression of specific WNT signaling factors and
epigenetic modulators will induce increased epithelial differentiation in APC mutation-negative organoids in
comparison to APC mutation-positive organoids. The proposed studies will provide essential knowledge of the
DNA methylation and gene expression changes underlying AA CRCs and will characterize cancer cell
responses to chemical challenge. The new knowledge will provide translatable information, including
diagnostic and predictive biomarkers and precision-medicine approaches, that could be used to treat a novel
subtype of CRC that occurs in excess in AAs and is associated with earlier age of onset.

Public health relevance
African Americans have a higher incidence rate of colorectal cancer and colorectal cancer diagnosed before age 50 constitutes over 15% of all colorectal cancers diagnoses—a major cancer health disparity. We have discovered a subtype of colorectal cancers that lack mutation in the APC gene that is associated with earlier ages of diagnosis and a novel epigenetic signature that impacts cancer stem cell maintenance. We will characterize the DNA methylation and transcriptomic signatures and interrogate with genetic and chemical perturbations the pathway-specific vulnerabilities of this subtype, leading to the identification of gene targets and enabling development of precision-medicine approaches to earlier age of onset colorectal cancers in African Americans.